Next-generation optical nanoprobes: From quantum biosensing to cellular monitoring

PROJECT SUMMARY
Our research program is directed towards innovating and advancing optical tools for the visualization and
quantification of latent biomolecular processes across multiple levels of biological organization. The MIRA
project will support and improve our analytical toolkit, which spans from surface-enhanced Raman
spectroscopic (SERS)-based molecular imaging probes to self-actuating single-cell analysis platforms and
biomimetic structures for cellular mechanotyping. Crucially, with support from the MIRA proposal, we will
develop three new, complementary platforms to address pressing questions in multiplexed molecular analysis,
intracellular magnetic sensing, and targeted imaging of cells and tissues.
First, we plan to realize a novel Raman spectroscopic sensing method by fusing SERS with coherent vibro-
polariton interactions in the strong coupling regime. While highly desirable, achieving vibrational strong
coupling (VSC) between ground-state molecular vibrations and an optical cavity has remained elusive.
Combining SERS nanoprobes with rationally designed Fabry-Perot cavities, we present a practical scheme to
render VSC that would simultaneously enhance the strength of Raman scattering and enrich its spectral
features paving the way for ultrasensitive and highly multiplexed analyte detection.
Second, we aim to develop an ultrasensitive nanoscale magnetometer to probe spin effects in biomolecules,
an important but poorly understood quantum effect in biological systems. We will implement a DNA-assisted
self-assembly approach to pair nitrogen vacancy-center in nanodiamond (NVnD) with plasmonic nanocavities.
The accompanying enhancements in NVnD sensitivity and spatiotemporal resolution will permit the detection
of currently undetectable ion flux-induced weak magnetic fields (WMF) and to examine the role of WMF in
affecting the spin dynamics of cryptochrome-generated radical pairs.
Third, we seek to harness biocompatible click condensation reactions to create a new class of synthetic
peptide-based Raman imaging nanoprobes involving enzyme-regulated intracellular self-assembly. Our
nanoprobes offer multiple advantages for targeted cellular imaging: higher accumulation and reduced efflux
due to in situ probe assembly; high sensitivity due to the presence of repetitive units of a π-conjugated
functional group in a single structure; and exquisite specificity owing to the easily distinguishable vibrational
mode in the cell silent spectral region.

Public health relevance
PROJECT NARRATIVE By leveraging optical spectroscopy, nanofabrication, and machine learning, this proposal advocates the development of three innovative platforms for ultrasensitive molecular sensing and nano-imaging in diverse biological systems. We propose to develop highly sensitive and spectrally enriched Raman sensing approach for multiplexed molecular detection by realizing surface-enhanced Raman spectroscopy in the strong coupling regime. We also seek to employ self-assembly principles to: engineer a highly sensitive nanoscale magnetometer for intracellular quantum sensing; and design a new class of Raman-active peptide-based nanoprobes for targeted cellular imaging.